Computational methods to decipher somatic alterations in cancer genomes

Project Summary
Cancer genomics has transformed the study and treatment of cancer. Nevertheless, the interpretation of
genetic alterations observed in tumor samples remains a major challenge in both basic science and clinical
settings. The functional roles of the vast majority of somatic alterations observed within cancer cells are
unknown: it is typically not known if a specific mutation plays a role in cancer growth or anti-cancer immune
response, or what impact (if any) an observed alteration has on cellular pathways. These gaps in knowledge
are major impediments towards personalized cancer treatments, from uncovering actionable mutations that
can be targeted by drugs to designing personalized cancer neoantigen vaccines. Further, for diverse
population groups to reap the benefits of cancer genomics, it is critical to develop computational methods that
explicitly consider genome variation and that are designed to identify and potentially mitigate inequities. Our
long-term goal is to develop computational approaches that work well across diverse populations in identifying
medically relevant alterations within cancer genomes. We have developed a powerful suite of methods to
discover cancer driver genes based upon integrating observed somatic mutations with knowledge about
cellular networks and a multidimensional view of protein functionality at the level of individual sites. We will
build upon on our prior work by devising machine learning approaches to predict which specific somatic
mutations within genes drive cancer, along with software to visualize and interpret mutations with respect to
newly derived protein functional features. We will introduce integrative formulations to uncover the impact of
somatic alterations on downstream genes and pathways. We will devise approaches to uncover immune-
relevant somatic mutations based on predicting interactions between major histocompatibility complex proteins
and peptides mutated in cancer. We will design our approaches to be effective as well as equitable across the
diversity of human populations. We will release open-source implementations of the developed computational
methods. This project will advance the state-of-the-art in computational methods for interpreting cancer
genomes, deepen our understanding of cancer biology, and move the field further towards unlocking the
promise of personalized cancer treatments in an equitable manner.

Public health relevance
Narrative A major challenge in medicine is to better understand and treat human cancers. In this proposal, we aim to develop novel computational methods to analyze cancer genomes in order to help uncover alterations that play an important role in cancer development or that can elicit an anti-cancer immune response. Application of our approaches will not only advance our understanding of basic cancer biology but also improve prospects for personalized cancer treatments.